Trisomy 21 and RNA polymerase II function

Project Summary/Abstract A signature feature of Down syndrome (DS) cells with trisomy 21 (21T) is misexpression of thousands of genes on all chromosomes but the underlying mechanism that accounts for this paradoxical situation is a mystery. Widespread gene misregulation is almost certainly an important causal factor in many of the clinical challenges faced by individuals with DS such as intellectual disability, heart defects, leukemia, and accelerated senescence with early onset Alzheimer's disease. We will test the hypothesis that trisomy 21 causes changes how RNA polymerase II (pol II) works in fundamental ways that have consequences for expression of the thousands of genes that are transcribed by this enzyme complex. We will map for the first time the global landscape of pol II transcriptional activity by nascent RNA sequencing of isogenic euploid and 21T iPSCs before and after neuronal differentiation. We will also test whether three fundamental steps common to the mechansim of transcription at all genes are altered by 21T: a) promoter proximal pausing, b) elongation speed and c) termination at the 3' ends of genes. This idea is a plausible one based on recent work from our lab and others showing that 1) pausing and termination are regulated in response to stress stimuli that are likely mediated throught the actions of kinases and phosphatases acting on components of the pol II transcription apparatus 2) the DYRK1A kinase, encoded within the Down syndrome critical region of chromosome 21, phosphorylates RNA pol II directly. A substantial body of research demonstrates that DYRK1A is over- expressed, and that stress-inducible signalling pathways are chroniclaly activated in DS. As a result pol II itself or associated elongation and termination factors could be abnormally modified in ways that cause widespread transcriptional changes. We will address these questions: 1. How is the genome-wide landscape of pol II transcription affected by trisomy 21? 2. How is “promoter proximal pausing” affected by trisomy 21? 3. How is transcription elongation rate affected by trisomy 21? 4. How is transcriptional pausing within genes affected by trisomy 21? 5. How is genome-wide pol II transcription affected by DYRK1A copy number? 6. How is in vivo pol II CTD phosphorylation affected by DYRK1A?

Public health relevance
Project Narrative A signature feature of Down syndrome (DS) cells with trisomy 21 (21T) is that thousands of genes throughout the genome are misexpressed, not just those on Chromosome 21. This paradox remains one of the major mysteries about DS. In this proposal we will test a new idea to account for global gene misregulation in DS. This model hypothesizes that fundamental steps in transcription by RNA polymerase II including how fast it moves, where it pauses, and where it terminates are globally altered in DS. These changes in RNA polymerase II function could be caused by abnormal activation of signalling pathways known to occur in DS or by elevated expression of the DYRK1A protein kinase encoded on Chr 21 which phosphorylates RNA polymerase II directly.